NeuroVision™: A Smartphone Application for Neurology and Telemedicine

The transformative shift in healthcare to in-home telehealth services is projected to deliver long term benefits
beyond the COVID pandemic to vulnerable populations, and those underserved due to isolation from specialty
care centers. For the neurologist, however, the shift away from in-person care has disrupted the ability to
perform comprehensive motor assessments with current telehealth technologies. While video conferencing
platforms have enabled some neurological evaluations of speech, facial, and upper body symptoms, most
neurological disorders such as Parkinson’s disease (PD) require a comprehensive visual examination of different
movement tasks and motor symptoms that are all too easily obstructed by the narrow field-of-view and
constrained 2D visual display of standard telehealth video-conferencing interactions. To overcome these
limitations and offer quantitative outcomes, our team of computer vision experts is partnering with leading
neurologists to develop a remote means of recording and quantifying prescribed neurological motor assessment
tasks in the home using a smartphone (3D) depth-sensing camera to inform a subsequent telehealth visit with
video samples and corresponding numerical outcome metrics. While developments from our group and others
in the area of computer vision have used total body pose estimation algorithms and stationary 3D cameras to
measure joint mechanics, our pilot work demonstrates the feasibility of a new approach to derive neurological
outcomes of gait, transfer, and fine motor assessment tasks directly from depth data recorded from a
nonstationary (handheld) smartphone. In Phase I we will build upon this work to develop simultaneous
localization and mapping algorithms in Aim 1 to obtain outcome measures of motor impairment from n=10
participants with PD that achieve +/- 5% error with respect to gold-standard motion capture. Aim 2 will add
guided instructions, compliance feedback, and summary reports to the software. The resulting NeuroVision™
prototype will be clinically evaluated for usability and perceived value among n=5 independent neurologists
and n=10 of their patients with PD. Smartphone-based recordings will be acquired by the patient’s care assistant
or family member using the NeuroVision™ app in our laboratory. The resulting report will be provided to the
referring neurologist, to be used to inform a scheduled telehealth visit. Our milestones are to achieve favorable
Likert usability ratings (≥8/10) and high ratings of perceived clinical value and acceptance from the neurologists.
Focus groups involving the patient and caregiver will provide additional feedback for a designing a more
complete Phase II NeuroVision™ system that meets in-home use requirements, supports a broader range of
common neurological conditions, and provides a secure eHealth assessment report. The pre-commercial
prototype will be tested for usability and clinical value in informing telehealth follow-up visits to meet the needs
of a broader population of at-risk patients with PD, Essential Tremor, Stroke, and Huntington’s disease currently
in need of safe and reliable access to routine clinical care for health and quality of life.

Public health relevance
PROJECT NARRATIVE The shift towards a greater reliance on telehealth delivery for neurological care has created a need for effective technologies beyond existing videoconferencing platforms to provide a surrogate means of assessing changes in motor symptoms without relying on in-person visits. This project addresses the need by developing NeuroVisionTM, a smartphone-based app for home use that leverages new depth-sensing camera technology to guide the user in recording prescribed motor assessment tasks in the home that are automatically quantified into clinical outcome measures with contextual video samples that are made available to the neurologist as an eReport to inform a telehealth visit with the patent. This project responds to the NIH mandate for more effective remote delivery of evidence-based practice during the global pandemics and beyond.